Intradialytic Myocardial Stunning in Hemodialysis Patients - a Novel Cardiovascular Risk Factor

Despite rigorous investigations and the expenditure of nearly 6% of Medicare funds on their care, annual
mortality among the 511,000 dialysis patients in the United States is extraordinarily high. Approximately, 17%
of patients die annually with half of deaths attributable to cardiovascular (CV) causes, particularly sudden
cardiac death. Current therapies do not effectively lower CV mortality in hemodialysis (HD) patients thus
highlighting the importance of addressing existing gaps in understanding of the mechanisms underlying CV
complications in HD patients and identifying novel therapeutic targets. Transient intra-dialytic myocardial
stunning (IdMS) during HD—the dominant dialysis modality in the US—has been increasingly implicated as
one such mechanism potentially responsible for progressive myocardial damage and subsequent development
of heart failure, arrhythmia, and CV death. However, current understanding of this novel risk factor is woefully
incomplete. Prior studies were small, included few women, non-white, or incident patients—those with the
highest risk of CV death—and variation in estimated prevalence was extreme (20-100%). In addition, studies of
IdMS risk factors were underpowered and conflicting, and it is remains unknown whether IdMS occurs
intermittently or repetitively. Finally, although our both our own preliminary data and studies by other groups
implicate a potential role for autonomic dysfunction in IdMS pathophysiology, there have been few mechanistic
investigations and understanding of the underlying pathophysiology is incomplete.
In short, IdMS is a potentially important and treatable contributor to CV death in the HD population, but there
are major gaps in understanding its epidemiology, risk factors, and mechanisms. We propose studies designed
to address these critical knowledge gaps and provide the necessary information to determine whether and how
IdMS should be targeted to reduce CV mortality in HD: In Aim 1, we propose performing intradialytic
echocardiography on a large, diverse cohort of 400 incident HD patients to facilitate stable, generalizable
estimates of IdMS prevalence, the analysis of important subgroups, and the study of associations with key risk
factors. In Aim 2, we propose a comprehensive investigation of the hypothesis that unopposed surges in
sympathetic tone underlie susceptibility to IdMS. Myocardial 11C-hydroxephderine PET scanning and dedicated
studies in an autonomic function lab will be utilized to assess systematic and myocardial-specific autonomic
function. Conversely, intradialytic autonomic tone and circulating hormones will be measured during dialysis to
systematically define the patterns of change in autonomic tone preceding and predisposing to episodes of
IdMS. These studies will improve understanding of the epidemiology and physiology of a potentially critical
contributor to cardiovascular morbidity and mortality in the dialysis population, improve basic understanding of
the pathophysiologic impact of HD on the heart, and provide the necessary data to design targeted
therapeutics to reduce CV death for high-risk patients.

Public health relevance
Project Narrative Hemodialysis patients have a high incidence of cardiovascular death despite use of an outsized proportion of Medicare funds on their care. Our proposal will improve understanding of the epidemiology of and mechanisms underlying transient intradialytic myocardial stunning, a novel and potentially critical complication of hemodialysis that may damage the heart and increase cardiovascular mortality. These studies will provide the necessary data to design trials of novel therapies to prevent intradialytic stunning and advance progress towards novel, life-saving therapies for this high-risk population.